Commercial Fishing Safety Training and Materials Development

Abstract The objective of this project is to reduce work-related fatalities and injuries among commercial fishermen. This objective will be achieved through training new instructors in two high risk regions, direct training of commercial fishermen in those regions, updating and enhancing existing educational materials and developing new materials, distributing those materials through conventional and new media channels, and the production and acquisition of new and innovative training equipment. The participants in this training will be commercial fishermen and are not degree seeking students. Instructors in this program will mostly come from the fishing industry and teach a variety of required and desired marine safety topics. The outcome of this project will be 280 fishermen trained in conducting Emergency Procedures Drills, 80 fishermen trained in Fishing Vessel Stability Awareness, and 16 new marine safety instructors, all within California, Oregon, Washington, and Alaska. Additional outcomes are the production and distribution of new and updated educational information online and in print, production and distribution of new digital training video content, and the production or purchase of new and innovative training equipment to support training classes. Research to Practice (r2p) plays a significant role in this project. Research in Coast Guard and National Transportation Board casualty investigations, and NIOSH, and others’ research papers regarding the causes of injuries and fatalities, inform many of the learning objectives in the curriculum and educational materials, distributed to commercial fishermen at large through training, online digital media, and print media. This proposal conforms to all components of 46 U.S.C. § 4502 (i) Safety Standards and addresses the NORA Agriculture, Forestry and Fishing objectives that pertain to commercial fishing safety training as follows: 1. Reduce the risk of fatal and non-fatal injuries in the commercial fishing sub-sector. Rational: Effective training in the use of survival equipment and procedures has been demonstrated to lower the rate and number of fatalities in commercial fishing. 2. Increase safety and health data meshing, information sharing, and collaboration among fishing safety researchers for workers in the fishing sub-sector. Rationale: Collaborate with researchers on both coasts to assist in program design and execution using expertise in fishing vessel safety.

Public health relevance
Project Narrative Commercial fishing continues to have one of the highest rates of fatal injuries of any major occupation in the US, despite the fact that fatality rates have been falling for 30 years. Accessibility to the protective effects of high quality, skills based fishing safety training continues to be a barrier due to a lack of port-based, accessible fishing safety instructors. This project will enhance both the quantity, quality and availability of safety training for commercial fishermen by supporting and expanding the number of commercial fishing safety trainers in U.S. ports through AMSEA’s Coast Guard accepted instructor-training course and coordinate with other existing commercial fishing safety programs in sharing resources, coordination of training, promotion and other aspects, to provide affordable, accessible, relevant, hands on training to fishermen in West Coast states and high schools in Alaska.